Targeting Hsp90 in cryptococcal fungal pathogenesis

Summary/Abstract
Intrinsic and acquired drug resistance of pathogenic microorganisms poses a grave threat to human health and
has enormous economic consequences worldwide. Fungal pathogens present a particular challenge because
they are eukaryotes and share many of the same biological processes as the human hosts they infect. Among
the most problematic fungal pathogens are species of Cryptococcus, which cause over 180,000 deaths per year
across the globe. Cryptococcal meningitis, the major clinical manifestation of the disease, has a 100% mortality
rate if left untreated. Even with best available therapies, mortality rates remain high because the number of drug
classes that have distinct targets in fungi is very limited and the usefulness of current antifungal drugs is
compromised by either dose-limiting host toxicity or the frequent emergence of high-grade resistance. New, non-
cross-reactive targets for therapeutic intervention are urgently needed.
In work performed with prior support from NIAID, we have shown that targeting the molecular chaperone Hsp90
in Cryptococcus and other fungi provides a powerful strategy to enhance the efficacy of antifungal drugs and
abrogate drug resistance. The “druggability” of Hsp90 has been well established by many small molecules
targeting this protein for the treatment of human cancers. The poor antifungal activity and toxicity of currently
available drugs, however, demand development of fungal-selective inhibitors as proposed in this revised
resubmission.
To pursue the goal of fungal selectivity, our interdisciplinary team has now solved the structure of the drug-
binding domain of Candida albicans and Cryptococcus neoformans Hsp90, both in unbound and inhibitor-bound
states. These chemo-structural studies identified fungal-specific differences in conformational flexibility that
allowed us to design, synthesize and characterize fungal-selective inhibitors of a new chemical class. Now,
leveraging the new chemistry and structure-based design approaches we developed with previous funding, we
will use our complementary expertise in fungal chemical and molecular biology (Cowen) and medicinal chemistry
(Brown) to continue pursuing structure activity relationship (SAR) studies, but now augmented by newly
developed computational algorithms to generate inhibitors with broad-spectrum antifungal activity. The efficacy
of compounds alone and in combination with a standard antifungal will be tested in culture and in mice against
drug-resistant C. albicans and C. neoformans. In addition to generating important basic insights, our results are
likely to impact the treatment of invasive fungal infections in the near future by providing promising leads for
development of actual antifungal drug candidates that operate in a new way.

Public health relevance
PROJECT NARRATIVE Infections by fungi pose an escalating health problem, with a global disease burden affecting billions and killing more than 1.5 million people annually. Successful completion of this project will deliver one or more optimized chemical compounds that can kill hard to treat fungi, especially cryptococcal species, and make current antifungal drugs work better by blocking resistance mechanisms. By providing valuable leads for future development into drugs, it will ultimately help generate greatly needed new, more effective antifungal antibiotics.